Learning and Discovery in Experimental Environmental Health Science: On the Path from Data to Knowledge

To achieve a healthy society, America needs both highly trained health professionals and a science-literate
public. The development of both begins during K-12 education. Within the NIH, the SEPA program provides
the principal means to influence pre-college science education. Our application builds on current infrastructure,
which provides ca. 1700 high school students per year, many of them from underrepresented groups, with
authentic scientific experiences based on experiment modules that utilize live organisms as biomedical models.
Students investigate the impacts of environmental/life-style chemicals on fundamental biological processes. In
the process, ca. 20 pre-service teachers per year learn to teach with an inquiry-based approach. Moving forward,
the proposed SEPA program will i) engage in-service and pre-service teachers and students with an in-depth
introduction to the scientific method and its components that is closely linked to the conduct of the experiment
modules. A major focus will involve analytical applications of data science that emerge after aggregating large
amounts of data submitted by students to a computational portal and data repository. Complementing this novel
emphasis, ii) student experimentation will be placed within a context of science and society, called environmental
health civics – a history of environmental chemicals in relation to governmental regulation and chemical toxicity
research. Attention will be directed toward environmental justice, particularly issues which effect Milwaukee
youth, including lead (Pb) poisoning, through the use of a powerful on-line environmental health mapping
program from the EPA. Experiment modules and special student conferences will further develop this area.
Both i) and ii) will be fully aligned with the Next Generation Science Standards. In addition, we will iii) provide
new ways for early career teachers to implement our program as they transition from pre-service status to mature
in-service teachers. Finally, iv) we will transfer our program to an on-line format and partner with other
institutions to expand the reach of our pre-service teacher program. Content goals will be merged with our
objective to offer large numbers of minority and economically disadvantaged students research experiences with
our modules. Our Specific Aims are to 1. Introduce in-service and early career teachers to the principles of
data and data science in relation to our environmental health experiment modules. 2. Collaborate with the
University of Wisconsin-Milwaukee, UW-Stevens Point and Carthage College science teacher education
programs to certify 100 pre-service teachers in the principles and practice of scientific experimentation and
communication. 3. Provide 8,500 high school students with a) experiences in doing data and data science-
focused scientific research, and b) an understanding of the importance of chemical toxicology, including a focus
on environmental justice. 4. Work with the Milwaukee Public School System and other regional schools to
provide large numbers of low income and underrepresented minority students with research experiences. 5.
Develop a robust on-line version of our program. 6. Conduct a thorough evaluation of the entire project.

Public health relevance
This SEPA program will prepare pre-service, early career, and in-service teachers to provide large numbers of students, particularly disadvantaged and underrepresented students, with authentic research experiences linking biological concepts with societally relevant problems of environmental health/chemical toxicity. To become adept at doing and analyzing experiments, students will develop a solid comprehension of the elements of the scientific method and an introductory facility with computational analysis of large data sets. Conducting research within a framework of understanding the history of environmental chemicals and their implications for environmental justice, students will gain insight into relationships between science and society and, in the process, be stimulated to enter biomedical STEM fields.